Improving Survey/Cognitive Completions and Home Examination Successes in Wave VI of Add Health

Project Summary
Achieving high consent and response rates in nationally-representative longitudinal studies is a pressing
scientific issue. Wave VI of the National Longitudinal Study of Adolescent to Adult Health (Add Health) –
consisting of a web-based survey and cognitive functioning assessment (Sample 1), an in-person based
survey and cognitive, physical, and sensory functioning assessments (Sample 2), and a blood-based home
examination for both Sample 1 and Sample 2 – is now in the field. Over the last six months, we have fielded
our web-based survey and cognitive assessment in one state as part of Sample 1. In addition, we launched our
home exam in June 2022, where we are collecting blood to test for several risk markers for AD/ADRD,
including neurodegeneration and inflammation. This pilot has gone quite well in two very important ways. First,
our fieldwork processes are working well. Second, the data that we are receiving, both from the web-based
survey with cognitive assessment and the biological samples that will be used to test for AD/ADRD biomarkers,
are of high quality. At the same time, it is also already clear from our pilot fieldwork that achieving our survey
response rate goals and our home exam response rate goal is going to be very challenging. This may be in
part due to ongoing fieldwork hurdles related to the Covid-19 pandemic; the polarized social and political
context of the country is likely an issue as well, although both of these factors are difficult to ascertain. But
there are also key study-specific challenges, some of which were unanticipated when we proposed the study,
that make attainment of our survey response rate goals and our home exam response rate goal especially
difficult. These include the age range and extremely busy lives of our respondents (ages 40-49), the longer-
than-anticipated length of our survey and cognitive assessment instruments (especially for our in-person
Sample 2 survey), and the specific challenges of reaching our less-educated and racial/ethnic minority sample
members. Given the immense scientific potential of Add Health, particularly given the racial/ethnic and
socioeconomic diversity, age range, and overall poor health of participants, enhanced investment in methods
to increase consent and participation is needed. In response to the above challenges and opportunities, the
Specific Aims of this supplement are: 1) To achieve the highest web-based and cognitive functioning survey
response rate possible in Sample 1 of Wave VI, particularly among less-educated and minority respondents,
through three fresh strategies we will employ. 2) To achieve the highest in-person-based survey response rate
possible in Sample 2 of Wave VI, particularly among less-educated and minority group respondents, through
two key adaptations we will be making. 3) To achieve the highest possible home exam completion rate in Add
Health Wave VI, particularly among less-educated and minority group respondents. This will involve targeted
efforts toward achieving both a higher consent rate for the home exam and a high completion rate for the home
exam once respondents are consented.

Public health relevance
Project Narrative This supplement focuses on overcoming the challenges of consenting and completing Wave VI data collection among sample members of the National Longitudinal Study of Adolescent to Adult Health (Add Health). Data from Wave VI of Add Health have the potential to provide an unprecedented resource to document and explain disparities in cognition and functioning outcomes among US adults as they age into midlife and beyond. This supplement thus proposes innovative ideas and processes across all data collection components of Wave VI to help increase consent and participation rates overall and especially so among population subgroups at greatest risk for experiencing disparities in cognition and AD/ADRD risk across the life course.